OGILVY PUBLIC RELATION WORLDWIDE:1106301 [18-002759]

To continue the OCPL needs in Communications Guidance and Strategic Planning, Partnership Development, Public Education Program Development, and Media Relations, Writing Support, Digital Communications, and Material Development